MOLECULAR MECHANISMS OF FIBRINOLYSIS

CDMAS was used for analyses of protein and peptide sequences for mapping binding sites in two molecules involved in the fibrinolytic system. These proteins are plasminogen activator inhibitor type-1 (PAI-1) and its binding protein, vitronectin (VN). Attempts are being made to determine disruption schemes for the PAI-1/VN interaction, ultimately enhancing blood clot dissolution in the body.